Data Science Core

Project Summary: Data Science Resource Core
The central purpose of the Data Science Resource Core is to construct and implement digital infrastructure
that can warehouse, integrate, visualize, and allow interaction with the data products of the three specific aims.
This digital infrastructure will be implemented in the form of a multi-tier services-oriented architecture, reusing
an open source neuroscience data sharing platform. Where possible, industry standard third party tools and
services will be leveraged as a foundation for our work, to avoid rebuilding any components that are already
well designed and easy to use. The products of the other Research Projects will be collected via protocols that
are amenable to digital representation. These will then be unified via spatial registration in a common
coordinate system. Ensuring that the data have appropriate landmarks and that measurements of the spatial
extent of key images is a core operation for this endeavor. With data whose content are appropriate for
unification, it will subsequently be determined which digital format representation is most appropriate for each
data type, with the goal of making them easy to present in an online interface for the consumption of the
broader scientific community. Data files with the appropriate format will be made available on cloud storage on
the public internet. From here, a user-friendly web-based interface will be designed and implemented on top of
a platform for neuroscience data visualization, that itself reuses best-in-class open source visualization
software for the web. The interface will ensure that users can easily navigate between individual data sets and
also can visualize relationships between data sets across the domains from the other Research Projects. The
interface will enable the user to explore data collected about the major interneuron classes, as well as neurons
in the major motor pools via mouse click. To encourage broad sharing of the data resources we produce, high
quality metadata will be created to include with the data that conveys its provenance. Data products will be
enabled to have their own digital object identifiers (DOIs), incorporate compatibility with ORCID ids, and embed
RRIDs into the system as necessary. Core data products will further be shared through key federally supported
data sharing resources and by applying best practices to data format and dissemination techniques used.